Engineered Granular Hydrogels for Endogenous Tissue Repair

Abstract
Myocardial infarction (MI) and the resulting left ventricular remodeling may compromise cardiac function and
eventually result in heart failure. Although there are limited current treatment options for these patients beyond
re-perfusion, a number of biomaterial therapies are currently being developed and have even progressed to
clinical trials. Our lab with our clinical collaborators have been exploring the use of injectable hydrogels for over
a decade to provide both mechanical and biological signals to the heart during the acute phase of MI, to alter
the LV remodeling response and to improve cardiac function. Often, these hydrogels are delivered as a
“pocket” of material within the myocardium with initial cell interactions only at the hydrogel periphery; however,
we now look to design “active” strategies where the material design can guide tissue repair through porosity
and engineered hydrogel signals. To accomplish this, we propose the development and application of granular
hydrogels – comprised of assembled microgel subunits that exhibit shear-thinning properties for injectability
and inherent interstitial porosity for cell invasion. Our guiding hypothesis is that the injection of granular
hydrogels will permit cellular invasion to increase vascular density, matrix accumulation, and improve
functional outcomes after MI. Importantly, particle-based materials are also known to promote a pro-healing
response based on their structure, leading to early collagen deposition, which can be leveraged to promote
infarct stabilization. Due to the modular nature of granular hydrogels, we propose three Aims to better
understand their structure-function properties towards their translation as an MI therapy. In Aim 1, we fabricate
microgels with high-throughput microfluidic approaches to form granular hydrogels where biophysical features,
namely particle size and the introduction of inter-particle interactions, are altered. We explore how these
parameters influence cell invasion, the maturation of vascular structures, and improve cardiac function when
assessed in an ischemia-reperfusion MI model in rodents. In Aim 2, we then seek to understand how the
addition of biochemical signals in granular hydrogels, including the protease-degradation of select microgel
populations and local release of the chemoattractant stromal cell derived factor 1α further improve outcomes.
Lastly, in Aim 3, we look towards translation with the development of advanced microfluidics for the rapid
fabrication of granular hydrogels and then evaluate select compositions in a clinically-relevant ischemia-
reperfusion model in pigs. Our study is supported by extensive preliminary work and expertise, including
biomaterials development for cardiac repair (Burdick), microfluidic design for particle fabrication and scale-up
(Issadore), and animal models for the assessment of therapies for MI (Atluri/Gorman). The significance of
this work is potentially profound, as it develops an acellular injectable hydrogel treatment for MI by
recruiting endogenous cell populations in the early post-MI period to limit adverse LV remodeling.

Public health relevance
Narrative Myocardial infarction (MI) and the progression to heart failure is a major public health concern that puts a large economic burden on the healthcare system. We propose an innovative approach to treat patients after an MI, where injectable biomaterials are injected into the heart early after MI to provide mechanical and biological signals that can improve the healing response. We evaluate our approach in a clinically-relevant animal model of MI, which if successful represents a translational therapy that could impact the welfare of many patients.